Enhancing Diversity at the 8th Astyanax International Meeting (AIM)

Project Summary/Abstract
A central goal of biological research is to understand how the diversity seen throughout fauna is generated, and
how changes in environment and ecology lead to phenotypic differences. Naturally occurring genetic variation
has instrumental roles in driving phenotypic differences, both in the cases of adaptive changes seen across
evolution, but also in pathological underpinnings of human disease. Indeed, today it is well accepted that genetic
architecture has a fundamental role in disease susceptibility. Model organisms have been essential to our
understanding of the genetic mechanisms underlying biological processes, yet our understanding of naturally
occurring genetic variation impacts trait differences and disease susceptibility is limited. A central impediment to
addressing this question is the lack of a model system with naturally occurring differences that is also amendable
to genetic and experimental manipulation. The Mexican tetra, Astyanax mexicanus has been a powerful tool for
addressing how naturally occurring genetic variation alters phenotypes. The model has two distinctly different
forms: There are surface dwelling fish that live in above-ground rivers and streams and have functional visual
systems and pigmentation, contrasting with at least 30 cave-restricted populations which are blind and albino.
The past decade has seen an explosion in the number of genetic tools introduced in the system, the number of
phenotypes that are being studied, and the number of labs world-wide that are utilizing this model. Today,
Astyanax is a model for eye degeneration, sleep loss, stress, aggression, metabolism and insulin resistance.
The Astyanax International meeting is a biennial meeting that brings the group of researchers using Astyanax
and other non-traditional aquatic models together to discuss the latest progress in biological research and to set
the direction for the subsequent 2 years. The 4-day meeting draws an international crowd with groups coming
from North and Central America, Europe, and Asia. The 8th biennial meeting will be held in South Florida in Fort
Lauderdale. South Florida is a prime venue due to its large size, ease of access with two major international
airports, and multiple options for the venue. The meeting will be open registration, and we expect 90-100
attendees; The last Astyanax International meeting held in San Antonio in 2022 had 70 attendees, and we expect
that this number will increase as COVID concerns have largely subsided. The meeting will feature two keynote
speakers and over 30 (36 in total) speakers chosen from submitted abstracts. The meeting will also feature a
poster session, and short ‘lighting talks.” All talks (not including Keynote speakers) will be the same amount of
time, and we will focus providing opportunities for junior PIs and trainees to speak. This will give opportunity to
a wide range of students and scientists at different stages of their careers to feature their work. A central focus
of this Astyanax meeting will be on enhancing and promoting diversity, especially for underrepresented groups
(URM) from Mexico and Latin America. Financial support is being requested to help offset registration and other
costs for these URMs. Other costs will be paid from registration fees and vendor donations.

Public health relevance
Project Narrative Understanding how phenotypic diversity arises in both adaptive and pathological states is a fundamental goal of biological research. For decades, the blind cavefish, Astyanax mexicanus, and its conspecific surface-dwelling relatives, have been important systems for addressing how naturally occurring genetic variation influences phenotypic differences. This application will support and ensure diversity at the 8th biennial Astyanax International Meeting, which has been the premiere conference where groups utilizing this model and other non-traditional aquatic systems can gather, discuss the latest research and discuss how to advance the model.